SARS-CoV-2 tropism and immunomodulation in salivary gland

Project Summary/Abstract
SARS-CoV-2 has been detected in a variety of human tissues, including the salivary gland. While its behavior in
the respiratory tract has been widely studied, relatively little is known about how this virus interacts with oral
tissues and the local immune environment. The salivary gland may serve as a unique site of viral presence and
immunological modulation, particularly through pathways involving non-classical major histocompatibility
complex (MHC) class I molecules. This project aims to investigate fundamental aspects of the innate immune
response to SARS-CoV-2 within the salivary gland, with a focus on the molecular interactions between virus- or
host-derived peptides and components of the mucosal immune system. In particular, we will explore how antigen
presentation mechanisms may shape or reflect local immune activity in this tissue. Identifying such mechanisms
will advance our understanding of tissue-specific immune regulation and viral tropism. The proposed research
is designed to clarify basic molecular and cellular processes that underlie host-pathogen interactions in the oral
cavity. By studying immunological dynamics in the salivary gland, this work will contribute to a framework for
understanding mucosal immunity and may reveal foundational principles of immune surveillance in non-respiratory tissues.

Public health relevance
Project Narrative SARS-CoV-2 has infected more than half of the US population since the start of the pandemic and causes systemic and oral diseases. This study tests the hypothesis that virus-induced peptides in saliva exert immunomodulatory effects through mucosal immune system. Outcome of the proposed study may uncover novel targets and strategies for immunotherapeutics to reduce the risk of virus transmission and alleviate the oral diseases.